Virus-like intercellular communication in the nervous system

Abstract
Recent studies by our group have revealed that the neuronal gene Arc, a master regulator of
synaptic plasticity and information storage in the brain, acts as a repurposed retroviral Gag protein
that forms capsids with the capacity to transmit genetic information between cells. These findings
lead to a paradigm shift in the way we view both mechanisms of cognition and more generally
how cells can signal to each other. This transformative R01 application will address these
questions using a synergistic team of neuroscientists and virologists who will apply their expertise
to Arc, intercellular gene transmission, and neuronal development. We will determine what
genetic messages are transferred between neurons in Arc particles, how these particles enter
“target” neurons to deliver their RNA cargo to cell cytoplasm, and how delivery of this cargo
influences the neuronal and synaptic processes that underlie memory and cognition. The
methodologies to address these questions, as well as the potential impact of the answers, make
this application ideally suited to the transformative R01 mechanism.

Public health relevance
Narrative This transformative R01 proposal will explore a new communication pathway between cells that resembles endogenous retroviruses, which mediates memory and cognition in mammalian brains.